Stroger Hospital of Cook County (SHCC) MU-NCORP Renewal

PROJECT SUMMARY/ABSTRACT
John H. Stroger Jr, Hospital of Cook County (SHCC) in Chicago, Illinois is the major tertiary
care site for the Cook County Health and Hospital System (CCHHS). The majority of cancer
cases are from minority-underserved populations and are predominantly African American. The
SHCC MU NCORP plans to continue to strengthen and improve coordinated care and clinical
research for its minority population through participation in NCTN programs. Dr. Thomas E. Lad
will continue as Principal Investigator (PI). The SHCC MU-NCORP will Continue to foster
relationships with current cancer research bases to facilitate broad and improved participation in
cancer control, prevention, and care delivery research for breast, lung, prostate, gastrointestinal,
brain, hematologic, head and neck, and gynecologic cancers; facilitate transfer of state-of-the-
are quality oncology care and new technology to minority-underserved populations in their own
communities, through participation in NCI-approved clinical trials; focus on prevention, control
and survivorship as methods for reducing cancer incidence, morbidity and mortality; encourage
multidisciplinary cancer care and integrated research at the local level; participate in cancer
care delivery research which accrue to trials relevant to process improvement and
implementation activities by coordinating the existing infrastructural features of the Cook County
Health & Hospitals System and CountyCare's Managed Care Community Network; continue to
be a source of annotated tissue and blood samples for translational research projects such as
the Early Onset Malignancy Initiative and the Patient Derived Xenograft project; continue
scientific activity at the research base level by chairing an ECOG group-wide cancer control
study concerning reproductive issues of female cancer patients that was conceived, designed,
and initiated by the SHCC MU NCORP; and increase participation in symptom science
research.

Public health relevance
PROJECT NARRATIVE The purpose of this proposal is the renew the Minority-Underserved NCI Oncology Research Program at John H. Stroger, Jr. Hospital of Cook County in Chicago. The continuation of this valuable program is critically important to our minority patient population as it offers access to cancer care strategies that would not otherwise be available at our safety-net institution. It also contributes to the diversity of the study population in the NCTN.